Bioengineering core

SUMMARY – CORE B
Core B, the Bioengineering Core, will be directed by Dr. Zahi Fayad and serve all three Projects over all five
years of the Program. The goals of the Core include:
1) Streamlining all therapeutic experiments by developing and providing trained immunity-inhibiting
nanobiologics.
2) Facilitating the nuclear imaging projects by providing immuno-PET probes.
3) Ensuring the safe use and disposal of radioactive materials.
The already developed nanobiologics and PET probes will be invaluable for the success of this Program Project.
In addition, Core B’s strong chemistry experience will facilitate the development of additional nanotherapies and
imaging probes as desired throughout this Project.